Core--clinical core

The Clinical Core is responsible for overseeing the administration, scoring and assessment of all behavioral and neuropsychological diagnostic instruments within the Center. In addition, members of the Core specialized consultation, teaching and training of various assessment methods. The Core assures that only the most reliable and valid psychometric instruments are utilized for research diagnoses. These assessment measures are essential for determining the phenotype for learning disabilities; researchers have yet to accurately and reliably define the phenotype. Thus, it will remain markedly important for researchers and diagnosticians to utilize reliable behavioral assessment measures to assess all populations studied in subprojects 0001, 0002, 0003. Indeed, the Core's function and expertise is critical to the success of our proposed research projects. Specific Goals of the Clinical Core are to: A. Manage the selection of highly researched assessment instruments appropriate for behavioral, cognitive and psychological assessment of children and adults to test research hypotheses. B. Maintain an organized log of neuropsychological tools and instruments for use in research studies. C. Assist in the cognitive and psychological assessment of all research subjects. D, Keep up to date with current, well-validated behavioral and neuropsychological assessment measures. E. Assure that chosen staff personnel are well trained to administer assessment tests.